Rapid innovation of precision psychiatry interventions using dynamic systems modeling and ecological quasi-experiments

PROJECT SUMMARY/ABSTRACT
The US faces a mental health crisis; nearly 83 million Americans experience mental illness, but fewer than
50% of these individuals accessed past year mental health services. There is a critical need for highly
disseminable, potent mental health interventions. Standalone digital interventions offer promise for improving
clinical outcomes at scale; however, efficacy of these interventions to date is modest, likely due in part to
insufficient personalization to patient heterogeneity and to momentary changes in mental health symptoms.
The present study seeks to rapidly improve the efficacy of precision psychiatry digital health interventions by
developing real-world, person-centered maintenance models for psychopathology using ecological (i.e., in
patient’s daily lives) data and dynamic systems modeling. Dynamic systems modeling of repeated time series
data yielded by ecological momentary assessment (EMA) and smartphone sensors will be used to evaluate the
individual and interactive effects of empirical maintenance factors to understand each individual’s maintenance
system for psychopathology in their daily life. Just-in-time adaptive interventions (JITAIs) are prompts delivered
in-the-moment via smartphone at identified instances of risk for maladaptive behaviors. Although often
evaluated in aggregate across months, JITAIs could be conceptualized as ecological quasi-experiments that
induce use of specific therapeutic skills at observable times. Accordingly, this study will use micro-randomized
(in which the content of the JITAI is randomly assigned in the moment) JITAIs delivered at times of elevated
risk for maladaptive behavior based on the individual’s developed dynamic system to evaluate the effects and
mechanisms of specific therapeutic skills on outcomes of interest, to provide granular insight into treatment
mechanisms. Eating disorders are the ideal population in which to test proof-of-concept for these methods to
improve efficacy of precision psychiatry digital interventions, as they are characterized by easily measurable
maladaptive behaviors (i.e., dietary restriction, binge eating, compensatory behaviors), are maintained by a
complex intersection of biological, psychology, and social factors, and their frontline treatment, enhanced
cognitive behavioral therapy (CBT-E), is primarily comprised of behavioral skills. The aims are: 1) test the
hypothesis that person-centered dynamic models will describe risk for dietary restriction, binge eating, add
compensatory behaviors with ≥ 60% average goodness-of-fit, 2) test hypothesized effects and mechanisms of
CBT-E skills on eating disorder behaviors and primary maintenance factors using JITAIs, and 3) characterize
feasibility and acceptability of the standalone JITAIs. The study will enroll N = 170 adults with eating disorders
who will complete four months of ecological data collection and receive JITAIs to use CBT-E skills at times of
elevated risk for 10 weeks of the data collection period. The study will set the stage for future randomized
controlled trail to evaluate the optimized, standalone JITAI system, which will have the potential to substantially
improve access to evidence-based mental healthcare.

Public health relevance
PROJECT NARRATIVE There is an urgent need to develop effective and highly disseminable digital interventions to address the current mental health crisis in America. The present study will: 1) use ecological data collection and dynamic systems modeling to develop comprehensive, personalized risk models for eating disorder behaviors to inform the delivery of just-in-time adaptive interventions at times when individual patients are at risk for these behaviors, and 2) deliver micro-randomized just-in-time adaptive interventions at identified moments of risk to facilitate real-world testing of the effects and mechanisms of core therapeutic skills in an ecologically valid way. This study will have implications for future precision psychiatry efforts to personalize treatment for individual patients and digital interventions designed to deliver the right type of support to disrupt systems maintaining psychopathology, and yield an optimized, standalone digital intervention for eating disorders.